Ophthalmology Core Facility

OVERALL CORE PROJECT SUMMARY
This P30 Ophthalmology Core Facility provides ongoing support for NEI-funded Oregon Health and Science
University (OHSU) and Casey Eye Institute vision researchers. The four resource cores are: Bioimaging &
Confocal Microscopy; Gene Expression & Manipulation; Proteomics; and Data Science & AI. These shared
resources will provide equipment and the expertise of skilled personnel otherwise not available to individual
researchers working in a wide range of vision-threatening diseases, including cataracts, glaucoma, macular
degeneration, diabetic retinopathy, uveitis, pediatric eye disease, the physiology of vision and the genetics of
inherited retinal diseases. The Bioimaging & Confocal Microscopy core will support confocal microscopy studies
using state-of-the-art instrumentation for identification and high-resolution localization of proteins and fluorescent
in situ hybridization such as RNAscope. In addition, this core will continue to support small animal imaging
through maintenance of a Spectralis OCT for in vivo imaging of rodent eyes. The Gene Expression &
Manipulation core will provide instrumentation and technical support for a range of molecular methods to identify
changes in levels of gene expression and proteins, and for methods by which these responses can be
manipulated, such as RNAi silencing, gene overexpression, or gene editing by CRISPR/Cas9. In addition, it will
continue to provide DNA isolation services from patient blood samples and tissue. The Proteomics core will
provide access to advanced, high-throughput techniques for measuring changes in protein abundance and
modification in diseased and non-diseased ocular tissues, determining how proteins fold and interact with one
another, and how they regulate development. To reflect the ever-changing landscape of vision research, a new
Data Science & AI core has been developed. This new core will retain biostatistical services for NEI-funded
investigators such as analysis of complex RNA-seq datasets, large proteomics studies, optical coherence
tomography (OCT) and OCT angiography studies. In addition, this core will provide support for using and
accessing electronic health record (EHR) data as well as the use of AI in biomedical research such as image-
based disease classification, biomarker segmentation, and predictive analytics. All four cores are highly
complementary and, in combination with new programs designed to encourage communication between
clinicians and basic scientists, will increase discoveries with greater direct benefit to patients.

Public health relevance
PROJECT NARRATIVE: OVERALL COMPONENT This P30 core grant (“Ophthalmology Core Facility”) to the Oregon Health and Science University (OHSU) Casey Eye Institute will fund four resource cores and support vision researchers studying a wide range of blinding diseases. Each core provides sophisticated instrumentation and skilled expertise, which would otherwise be unobtainable by individual researchers. The cores will aid NEI-funded investigators with: (1) high magnification imaging of proteins in ocular cells, diseased and non-diseased tissue samples, and live-imaging technologies for small animal models; (2) methods to detect and quantify gene expression within cells and tissues, as well as advise researchers on how to activate or suppress their expression, to understand how specific genes contribute to eye disease; (3) proteomic methods to detect and quantitate proteins in eye tissues and how they are altered in normal and diseased eyes; and (4) expertise to support investigators who use artificial intelligence and informatics in their biomedical research, as well as provide sophisticated statistical support to analyze complex gene and population data sets